Linking diet, gut microbiota and autoimmune disease: Bacteria induced phytoestrogen metabolites impact immune function in Experimental Autoimmune Encephalitis

Although the link between the immune system and the gut microbiome is being increasingly appreciated, the
mechanistic links between the microbiome and inflammatory autoimmune diseases such as multiple sclerosis
(MS) are unclear. Thus, there is a critical need to define mechanisms by which gut bacteria maintain immune
homeostasis and thereby affect neuroinflammation. We have recently reported that MS patients have altered
gut microbiota compared to healthy controls, with a reduced abundance of certain human gut bacteria
(Parabacteroides, Adlercreutzia, and Prevotella) with the ability to metabolize phytoestrogen. Gut bacteria
metabolize phytoestrogen into equol which has structural similarity with estrogen, and can regulate immune
responses through estrogen receptors and AMP-activated protein kinase (AMPK). Our preliminary data
showing significantly milder EAE in mice on a phytoestrogen (Isoflavones) containing diet compared to those
on a phytoestrogen free diet suggest a critical role of phytoestrogen in modulation of EAE. Additionally,
Prevotella histicola, a member of the Prevotella genus, can suppress disease in experimental autoimmune
encephalomyelitis (EAE), a preclinical murine model of MS. However, the importance of phyoestrogen
metabolism in P. histicola–mediated disease suppression is unknown. The central hypothesis of the proposed
studies is that the human gut commensal P. histicola mediate its disease-protective effect through metabolism
of phytoestrogen and subsequent activation of immunoregulatory cells. We will test our central hypothesis
using animal model, genetically modified mice, and a cell culture approach in the following two specific aims. In
first aim, we will utilize P. histicola as a representative phytoestrogen-metabolizing gut commensal bacteria to
determine whether metabolism of phytoestrogen is required for ability of P. histicola to suppress disease and
induce Tregs and/or CD103+ Tolerogenic dendritic cells (DCs). We will determine the importance of AMPK
signaling in the phytoestrogen induced activation of Tregs and/or tolerogenic DCs. In second aim, we will
determine whether the phytoestrogen plus bacteria mediate the induction of immunoregulatory cells via
estrogen receptor (ER)-dependent pathways in intestinal epithelial cells and/or immune cells. Our study is fit
for the “High Priority Immunology Grant (R01) mechanism because we are proposing to determine the
mechanisms underlying the microbial impact on systemic immunity which can be harnessed in designing
potential mono as well as combination therapies because drugs with diverse non-overlapping mechanisms
might provide maximal benefit to MS patients. We will determine whether phytoestrogen-metabolizing bacteria
maintain a disease-free state by tilting the Tregs to Th1/Th17 balance towards Tregs through its interaction
with estrogen receptors and the AMPK pathway. We expect the outcome of our study will have a positive
impact on development of gut microbial-flora/diet-based therapies for MS as well as other inflammatory
autoimmune diseases.

Public health relevance
NARRATIVE Diet is one of the major factors regulating our gut microbiota and therefore the phrase that you are what you eat is so true. Our recent study points toward an important role of gut microbiota in regulation of inflammatory diseases such as MS. However how gut microbial flora predispose to or protect from MS is not known. In this study we are proposing to elucidate the mechanism through which certain gut microbiota with ability to metabolize plant derived chemicals might be beneficial to us. Successful completion of the study will help in determining the mechanism through which gut bacteria might provide health benefit to the host.